Statistical methods for TCR-sequencing experiments

Abstract
The full collection of T-cell receptors within an individual, their TCR repertoire, provides critical insight into and
information about the individual's ability to mount any kind of T-cell response. This response can be helpful or
harmful, ranging from eradication of an infection or destruction of cancerous cells to an auto-immune attack on
the body itself. Technologies have recently been developed that allow for TCR profiling in individual cells
providing opportunity to identify rare clonotypes and characterize the TCR repertoire at unprecedented levels of
resolution. Unfortunately, much of the potential has yet to be realized as statistical methods to analyze high-
throughput TCR-seq data are lacking. This proposal addresses some of the most critical statistical deficiencies
that are currently preventing the scientific and clinical communities from turning valuable high-throughput TCR
profiling measurements into meaningful results. In particular, we propose statistical methods to ensure that
functional TCRs are not lost in pre-processing as well as methods to identify the clonotypes that are most likely
to impact disease-relevant immune response. Taken together, successful completion of the project will help to
ensure that maximal information is obtained from powerful TCR-seq experiments.

Public health relevance
Project Narrative Technologies have recently been developed that allow for TCR profiling in individual cells providing opportunity to characterize the TCR repertoire at unprecedented levels of resolution. However, to achieve its potential, novel statistical methods are required for TCR-sequencing data analysis. The proposed methods address some of the most important statistical and computational deficits facing investigators using single- cell TCR-sequencing data. Their development is required to ensure that maximal information is obtained from single-cell TCR-sequencing experiments.